Resonant Frequency rTMS: A Novel Approach to Target Circuit Modulation in MDD

ABSTRACT
Repetitive Transcranial Magnetic Stimulation (rTMS) is effective for treatment of Major Depressive Disorder
(MDD). Clinical improvement with rTMS is believed to reflect engagement of a target mood-regulating circuit.
This innovative proposal aims to enhance target circuit engagement through stimulation at an
individual’s optimal resonant frequency (RF). Circuit connectivity is maintained by oscillations at one or more
RFs specific to that circuit for that individual. Personalizing stimulation frequency is an opportunity to optimize
rTMS effectiveness, but there has been no method to identify optimal RF for rTMS treatment in a patient-specific
way. We developed a novel TMS-electroencephalography (TMS-EEG) “interrogation” method that identifies RFs
by examining the degree of resonance induced by stimulation frequencies from 5–18 Hz for a target circuit
originating in left dorsolateral prefrontal cortex (DLPFC). Frequencies are then ranked based on resonance
properties (degree to which they increase connectivity in the target circuit) and the highest-ranked frequency is
identified. Our pilot data suggest that MDD treatment at maximum RF (rTMSRF-MAX) rapidly modifies connectivity
and leads to early symptom improvement, providing preliminary support for a RF-based personalized approach
to rTMS. This project will provide a mechanistic understanding and validation of the RF approach through three
aims and hypotheses: 1. Establish reliability of a method for RF determination in a DLPFC-based target
circuit. H1: An individual’s RF median values and rankings will be stable across repeated measurements; 2.
Demonstrate superior neurophysiologic engagement of the target circuit with rTMSRF-MAX stimulation.
H2: rTMSRF-MAX will be associated with greater increases in connectivity in a left DLPFC-based target circuit than
rTMS at the lowest ranked resonant frequency (rTMSRF-MIN); 3. Contrast the neuroanatomic distribution and
degree of target circuit engagement by rTMSRF-MAX and rTMSRF-MIN stimulation. H3: Whole-brain EEG source
localization will display a distinct distribution and degree of regional brain activation following rTMSRF-MAX and
rTMSRF-MIN, with rTMSRF-MAX better engaging circuits previously reported to be related to antidepressant
response. 80 MDD subjects will undergo TMS-EEG interrogation at a neuroanatomically-defined left DLPFC
region. We will measure the resonance profile across the 5-18 Hz frequency range on three occasions for each
individual to evaluate the temporal stability of RF measurement. Subjects then will undergo separate stimulation
sessions with rTMSRF-MAX and rTMSRF-MIN. We will compare the two frequency conditions with regard to the
degree of stimulation-induced changes in EEG connectivity in the target circuit. Finally, we will utilize EEG
source localization to determine the neuroanatomic distribution of the connectivity effects of rTMSRF-MAX vs.
rTMSRF-MIN, and compare the distribution to determine if rTMSRF-MAX better alters connectivity within previously
reported treatment-responsive circuits. Findings provide a foundation for a novel personalized rTMS approach
and inform design of a future clinical trial to test whether the rTMSRF method enhances treatment outcomes.

Public health relevance
Project Narrative Repetitive Transcranial Magnetic Stimulation (rTMS) administered at a frequency of 10 Hz to the left dorsolateral prefrontal cortex (DLPFC) is an effective treatment for Major Depressive Disorder (MDD), yet many patients do not obtain significant benefit. This study aims to develop an innovative personalized- medicine approach to rTMS using a novel “interrogation” procedure, which examines electroencephalogram (EEG) signals recorded from the scalp following different stimulation frequencies to identify the frequency that is most likely to engage brain circuits associated with rTMS antidepressant response for each individual. Results will lay the foundation for a future clinical trial to investigate the efficacy of this customized stimulation approach to treating MDD.